Transplantation of hearts from donation after circulatory death

Heart transplantation (HTx) is the ultimate treatment for end-stage heart failure, but its use is limited by the
availability of donor hearts. As a result, a substantial number of HTx candidates die awaiting transplant.
Donation after circulatory death (DCD) offers a promising additional source for HTx. However, its adoption is
hindered due to obligatory warm ischemic injury during death process and subsequent reperfusion injury, as
well as unsuitable preservation modality during transport. The EVHP provides normothermic perfusion platform
for satisfactory preservation of DCD hearts and offers the possibility to deliver therapeutic agents that improve
resuscitation of DCD hearts prior to transplantation. Given stem cell-derived paracrine protection following
myocardial ischemia, our goal is to determine potential efficacy of post-ischemic administration of stem cell
secretions (conditioned medium [CM], extracellular vesicles [EVs], or engineered EVs) using the EVHP on
recovery of DCD hearts prior to transplantation, thereby increasing the number of available donor hearts. Our
recent studies have reported that adding MSC-CM or MSC-EVs to storage solution protected heart graft
performance after 6h-cold storage using an in vivo mouse HTx model and MSC-CM restored cold ischemia-
impaired cardiac transcriptome profile. These results suggest therapeutic potential of MSC secretions on donor
heart preservation. Our published work and preliminary data have also shown: 1) using human MSCs or their
CM improved heart functional recovery in the EVHP following acute ischemia/reperfusion (I/R); 2) MSC-CM
prevented mitochondrial damage in donor hearts from cold ischemia and restored clock gene period 2 (Per2,
with a role in mitochondrial metabolic regulation); 3) warm ischemia resulted in abnormal mitochondrial
structure in mouse and human DCD hearts, with decreased Per2, and 4) Per2 knockdown worsened
mitochondrial injury and abolished MSC CM-mediated mitochondrial preservation in myocytes during stress.
Collectively, we hypothesize that post-ischemic administration of MSC secretions using the EVHP ameliorates
warm ischemia-induced functional deterioration of DCD hearts via Per2-elicited mitochondrial improvement.
We expect that a novel approach using the engineered EVs to deliver Per2 will promote mitochondrial
recovery and myocardial resuscitation in DCD hearts. We propose two aims: 1. test the hypothesis that ex vivo
application of MSC secretions using the EVHP ameliorates warm ischemia-induced myocardial damage via
mitochondrial preservation in DCD hearts; and 2. determine the role of Per2 in improving mitochondrial
performance in DCD hearts and demonstrate beneficial effects of Per2-loaded MSC-EVs on resuscitation of
DCD hearts. The translational potential of MSC-derived therapy and the engineered EVs will also be assessed
in human-like porcine DCD hearts. The results from this study can provide foundation for potential clinical trials
in that MSC secretions can be utilized to improve DCD heart recovery and help us gain mechanistic insights on
therapeutic targets to limit warm ischemic injury in DCD hearts for transplantation.

Public health relevance
Project Narrative/Relevance Heart transplantation is an ultimate treatment for end-stage heart failure, but its use is limited by a severe donor heart shortage. This proposed study is aimed at evaluating mesenchymal stem cell (MSC)-derived therapy applied with an ex vivo heart perfusion device to facilitate recovery of hearts from donation after circulatory death (DCD, thus increasing the number of available donor hearts), promote graft function, and improve outcomes of heart transplantation. The results from this project can provide foundation for potential clinical trials in that MSC secretions can be utilized to improve DCD hearts resuscitation, and help us gain mechanistic insights on therapeutic targets to limit ischemic injury in DCD hearts for transplantation.